Targeting the BCL2 immune checkpoint to enhance the immunostimulatory effects of radiation in breast cancer

SUMMARY
Hormone receptor (HR)+ breast cancer (BC) causes the majority of BC-related deaths in the US, reflecting an
unmet need for innovative therapeutic approaches. Indeed, resistance to standard treatments and metastatic
spread remain major challenges, and novel approaches such as immune checkpoint blockers (ICBs) have shown
limited efficacy so far. The long-term objective of this proposal is to mechanistically dissect the impact of BCL2,
an antiapoptotic protein that favors the resistance of cancer cells to death imposed by chemotherapy and
radiation therapy (RT), on the immunological configuration of treatment naïve and irradiated HR+ BCs.
Specifically, this project will test the highly innovative hypothesis that BCL2 may represent a therapeutically
actionable immune checkpoint because of its ability to preserve mitochondrial integrity, based on these
specific aims: 1) determining the influence of BCL2 levels on the immune microenvironment of treatment-naïve
human and mouse HR+ BCs; 2) defining the impact of BCL2 on the immune microenvironment of HR+ BCs
responding to RT in vitro and in vivo; and 3) elucidating the value of BCL2 as a target to boost the
immunostimulatory effects of RT in mouse models of HR+ BCs, including an innovative model that mimics key
features of human HR+ BC. BCL2 is a particularly significant target because ~80% of HR+ BC cases
overexpress BCL2, and the BCL2 inhibitor venetoclax, is approved for clinical use. To achieve our goals,
diagnostic biopsies from women with HR+ BC will be evaluated by CODEX for BCL2 expression, tumor infiltration
by key immune cells that regulate anticancer immunity, and expression of immunosuppressive proteins like MHC
Class I and PD-L1. The impact of BCL2 on the immunological response of HR+ BC cells to RT will be interrogated
in vitro, by genetic (deletion, overexpression) and pharmacological (e.g., venetoclax administration) methods
coupled to flow cytometry, IF microscopy and ELISA for the assessment of key regulators of anticancer immunity.
Similar genetic and pharmacological approaches will be harnessed to alter BCL2 competence and delineate the
influence of BCL2 on the immunological TME of treatment-naïve and irradiated mouse HR+ BCs established in
immunocompetent hosts, based on IHC, flow cytometry and single-cell RNA sequencing. In vitro studies by flow
cytometry and clonogenic assays, as well as in vivo studies based on mouse HR+ BC cells growing in
immunodeficient vs immunocompetent mice, will be employed to dissect the impact of BCL2 on intrinsic
radiosensitivity vs immune-dependent tumor control. Finally, different combinatorial regimens involving RT and
venetoclax will be investigated for efficacy (in both treatment-naïve and treatment resistance settings) and
potential mechanisms of resistance in an endogenous mouse model of HR+ BCs that mimics key features of
human HR+ BC. Our findings will elucidate the impact of BCL2 on the immune TME of HR+ BC and identify
the best approach to inform the initiation of clinical trials testing RT plus venetoclax in women with HR+
BC, a devastating disease that still affects >200,000 and kills >25,000 new women every year in the US.

Public health relevance
NARRATIVE The studies proposed herein will determine the impact of BCL2, a protein that supports the survival of cancer cells responding to treatment, on the immunological configuration of hormone receptor (HR)+ breast cancer (BC), as well as the therapeutic value of combining radiation therapy (RT) with BCL2 inhibitors in immunocompetent mouse models of HR+ BC. These findings will provide preclinical ground to the initiation of clinical trials testing RT plus venetoclax (a BCL2 inhibitor currently approved by regulatory agencies for use in patients with chronic lymphocytic leukemia) in women with HR+ BC, a type of BC that still affects >200,000 and kills >25,000 new women every year in the US.